Investigating the Role of Wnt Signaling in the Mechanical Maturation of Tendon

PROJECT SUMMARY/ABSTRACT
Tendon injuries are one of the leading causes of disability within the United States, directly impacting
patients’ quality-of-life as even basic daily activities are impaired. This impairment is exacerbated by tendon’s
poor healing capabilities, typically producing a fibrotic scar with inferior biomechanical properties and increased
chance of re-injury. Despite their prevalence, clinical interventions report highly variable efficacy and new clinical
therapies are required. An improved understanding of the biological mechanisms underlying tendon formation
and maturation would better inform the development of new clinical strategies aimed at improving tendon
structure and function following injury and lead to more effective treatments for patients.
Here, we focus on a critical phase in postnatal tendon maturation defined by decreased tendon cell
proliferation, maturation of the matrix, and an abrupt increase in the biomechanical capabilities of the tendon.
While the timing may vary, this mechanical transformation is conserved across species and is critical to the
acquisition of load-bearing activities. While significant progress has been made in decoupling the underlying
structural elements that mediate this process, the cellular and molecular mechanisms regulating this
transformation remain unclear and may offer novel insights for the advancement of current clinical strategies.
Intriguingly, our preliminary data has identified that Wnt signaling and a Wnt-responsive cellular
population, marked by Axin2 expression, may play a crucial role in this key phase of postnatal tendon maturation.
However, further work is required to understand their contribution to tendon fate and the underlying molecular
mechanisms by which they are regulated. Therefore, the goal of this proposal is to elucidate the function(s) of
Wnt signaling in postnatal tendon maturation and test if mechanical cues contribute to an Axin2-lineage cell fate
and/or the regulation of Wnt signaling in the maturing tendon niche. Based on our preliminary data, we
hypothesize that Wnt signaling is integral for proper tendon cell behavior, gene expression, and
deposition/organization of the extracellular matrix, which ultimately define the mechanical fate of tendons, and
is regulated by mechanobiological signaling activity. In Aim 1, we will define the function of Wnt signaling and
identify Wnt-responsive cell populations during the establishment of this critical structure-function transformation
in postnatal tendons. In Aim 2, we will investigate if Wnt is regulated by mechanobiological signaling activity
during postnatal maturation and explore other molecular pathways and cell populations that are dependent upon
mechanical cutes during this critical phase of tendon development.
Altogether, this work will provide key insight into understanding the complex cellular population,
biomolecular, and biomechanical interactions which mediate the formation of a robust tendon matrix. These
principles will provide the framework for new regenerative strategies to improve human clinical treatments
following tendon disease or injury.

Public health relevance
PROJECT NARRATIVE: Postnatal tendons have demonstrated the ability to heal without the formation of a fibrotic scar and fully rescue their mechanical capabilities, suggesting they have a unique biomolecular niche that offers amplified regenerative potential. Preliminary data from our lab indicates that Wnt signaling and Wnt-responsive tendon cells contribute to tendon’s regenerative capacity and may play a key role in the acquisition of load-bearing capabilities during postnatal stages of tendon maturation. This proposal aims to elucidate the contribution of Wnt signaling and Wnt-responsive cells in tendon maturation and the establishment of tendon structure-function relationships with the goal of identifying novel therapeutic strategies to improve patient outcomes following tendon injuries.